Project 3 Engaging Educators around Classification Systems in Schools (T3)

PROJECT SUMMARY/ABSTRACT
The persistent misidentification of students with specific learning disabilities (SLDs) is a public health concern,
with dire consequences for children’s healthy academic and socioemotional development. Despite decades of
research on SLD classification, there is limited uptake and use of these findings in school assessment
practices, which include screening, progress monitoring, and comprehensive evaluation within a multi-tiered
system of supports. There is a lack of alignment between research-based and school-based classification of
SLD. While research evidence accumulated over decades provides relative certainty about how SLDs in
reading and oral language might be expressed in children, these prescriptive classifications are not always
reflected in the identification and eligibility processes that qualify students for support services in school. The
situation is particularly problematic for students from marginalized groups, who must demonstrate that their
underachievement is “unexpected” and not due primarily to environmental or economic disadvantage and
language or cultural differences. These criteria make it disproportionately more likely for children from race-
and ethnic-monitory groups and children growing up in poverty and under-resourced communities not to
receive adequate support services to address their learning difficulties or disabilities. This project aims to tackle
the research-to-practice gap in the uptake of evidence-based assessment practices (EBPs) used in schools to
recognize and respond to learning difficulties and disabilities. Specifically, we will leverage advances in
effective approaches to bidirectional community engagement and the field of implementation science to (a)
determine barriers and facilitators matched to culturally responsive strategies for implementing assessment
EBPs (Aim 1) and (b) determine the usability of a prototype packaged professional learning community for
supporting assessment EBPs (Aim 2). The work captured in both aims will be conducted in partnership with
schools and districts that serve substantive proportions of historically and systematically marginalized groups
and communities. Project sites represent a range of diversity that is representative of many communities
across the U.S, including urban and rural geographic locations, low-income households in under-resourced
communities, and race-, ethnic-, and language-minority groups. Following the broad themes in the RFA to (2)
further extend translational research; (5) enhance the research base on early prevention efforts; and ensure (6)
significant focus on diverse populations, this project addresses the call for a …required project [that] must
focus on examining engagement approaches with communities of interest to the themes of the Center. This
proposal embraces the diversity that is inherent in US public schools and elevates the challenges and
opportunities for developing the translational research base to ensure school success for all children.